The Geneticization of Education: ethical, social, and policy implications of polygenic scores for educational attainment

Project Summary
This proposal addresses the psychosocial impacts of a new kind of genetic information currently available to
the general public: polygenic scores for educational attainment (EA-PGS). Available for purchase via a growing
number of third-party, direct-to-consumer (DTC) genetic testing companies, an EA-PGS provides information
about an individual’s genetic propensity for completing years of schooling. To the extent that it is a genetic
predictor of a complex outcome with major social and environmental causes, EA-PGS research represents a
“geneticization” of education that engenders a host of difficult ELSI questions to be addressed by this K01
proposal. Who seeks out EA-PGS and why? How do DTC customers interpret and use their results? How does
exposure to EA-PGS research impact public attitudes toward education and schooling, including attitudes
about racial/ethnic disparities in education? To address these questions, this proposal includes a plan of
empirical research, including (Aim 1) qualitative research involving in-depth interviews with individuals who
have recently received EA-PGS results via DTC genetic testing company, Geneplaza, and (Aim 2) quantitative
research involving surveys of key stakeholder groups (students, parents of students, and educators)
randomized to read stories from the popular media emphasizing either EA-PGS or social influences on
education. Finally, this proposal includes (Aim 3) a plan of conceptual research, involving development of an
ethical framework on the potential harms and benefits of the geneticization of education, developed through
consultation with an expert advisory council of prominent scholars in education policy, ethics, and genetics.
Building on the PI’s strong background in behavior genetics and philosophy of science, these aims will be
achieved with an interdisciplinary, mixed-methods career development plan that includes training and
coursework in quantitative methods, qualitative methods, and bioethics. The career development plan is
supported by a team of highly experienced and esteemed Columbia University and Hastings Center scholars
with expertise in qualitative methods, quantitative methods, and bioethics: Paul Appelbaum, Sandra Soo-Jin
Lee, Ruth Ottman, and Josephine Johnston.

Public health relevance
Project Narrative This proposal seeks to investigate the ethical, social, and policy implications of a new kind of genetic information currently available to the public: polygenic scores for educational attainment (EA-PGS). The proposal includes a research plan to 1) qualitatively investigate individuals who have received EA-PGS results via direct-to-consumer (DTC) genetic testing, 2) quantitatively investigate how exposure to EA-PGS research in popular media influences attitudes about educational disparities in the US, and 3) develop an ethical framework on the potential harms and benefits of EA-PGS. The proposal includes a career development plan for the PI to complete training and coursework in qualitative methods, quantitative methods, and bioethics.